Impact of COVID-19 on Continuity of Care for Veterans on Antipsychotic Medications

Background: Severe mental illnesses are consistently ranked as some of the most debilitating health conditions
worldwide due to their early age of onset, chronicity, and impact on functioning. Fortunately, a number of
antipsychotic medications have been found to be effective for managing the symptoms of severe mental illness
(SMI) and for preventing relapse and rehospitalization. Despite their efficacy, treatment non-compliance for
individuals on these medications is high due to a number of factors including poor insight into illness, negative
attitudes about medication, and medication related side effects. Further complicating care and outcomes for this
clinical population, providers must maintain close oversight of patients on antipsychotics due to the impact of
these medications on metabolic and cardiac functioning which confer an increased risk of obesity, diabetes,
heart problems, and other chronic illnesses. This oversight includes regular monitoring of weight, blood pressure,
fasting blood glucose, and lipid levels. Additionally, clozapine, indicated for treatment-resistant schizophrenia,
requires weekly-to-monthly monitoring of absolute neutrophil counts to prevent potentially fatal clozapine-
induced agranulocytosis. Significance: The proposed project has significant and immediate relevance to
Veterans and the VHA in that it seeks to better understand if and to what extent COVID-19 related care
disruptions impacted care and outcomes for Veterans with SMI prescribed antipsychotic medications. Given pre-
existing challenges in the treatment of this Veteran population, this is an important area of inquiry as well as one
for which little is known. Added strengths of the proposed study include the use of a mixed methods approach
that includes national level data from multiple sources. Aside from addressing a critical knowledge gap, the
proposed study targets what is unarguably one of the most vulnerable patient populations within the VA and
other healthcare systems—patients with SMI prescribed antipsychotic medications. Specific Aims: Aim 1: To
assess the impact of COVID-19 related care disruptions on healthcare use and outcomes for Veterans on
antipsychotic medications using robust statistical methods and national level data; Aim 2: To assess whether the
impact of COVID-19 related care disruptions differ by race/ethnicity, gender, age, and rural/urban status using
national level data; Aim 3: To conduct thematic interviews with provider and patient stakeholder groups at the
national level to better understand COVID-19 related care disruptions. Provider stakeholders (e.g., psychiatrists,
advanced nurse practitioners) will be interviewed to better understand COVID-19 related changes in practice
behaviors, the perceived impact of these changes on care continuity and outcomes, and to solicit suggestions
to mitigate the impact of interrupted care in the future; Veterans prescribed antipsychotic medication
prescriptions in the pre COVID-19 window will be interviewed to better understand the impact of COVID-19
related care disruptions on treatment seeking behaviors, obstacles encountered with regard to access, and to
explore other factors potentially impacting outcomes in this patient group. Methodology: The proposed study
will employ a mixed-methods (quantitative/qualitative) approach. For Aims 1 & 2 we will employ retrospective,
observational analyses using a national cohort of Veterans (N>250,000) with an ICD-CM-10 diagnostic code for
schizophrenia or bipolar disorder prescribed a first-generation or second-generation antipsychotic [1/19-12/21].
Veterans of all ages, genders, racial groups, military eras will be included in the cohort. Aim 3 will involve
individual thematic interviews with provider (n=35-45) and patient stakeholders (n=50-60). Next
Steps/Implementation: Findings from this 2-year project will be of immediate relevance and impact for local,
regional, and national level administrators and mental health providers as well as the VA Office of Mental Health
and Suicide Prevention and VA Pharmacy Benefits Management Services. Collectively, data from this project
will serve to identify potential strategies to further mitigate the impact of COVID-19 on the care and outcomes of
Veterans with SMI as well as prepare for future public health and/or other national emergencies.

Public health relevance
Healthcare access for all Veterans was adversely impacted by COVID-19 safety-related guidelines. Disruptions in care for Veterans on antipsychotic medications are particularly concerning given the patient and system level costs associated with the suboptimal treatment and monitoring of this Veteran population. The proposed project has significant and immediate relevance to Veterans and the VHA in that it seeks to better understand how COVID-19 related care disruptions impacted healthcare delivery and outcomes for Veterans on antipsychotic medications. Aside from addressing a critical knowledge gap, the proposed study seeks to identify potential strategies to further mitigate the impact of COVID-19 on the healthcare of Veterans with severe forms of mental illness as well as prepare for future public health and/or other national emergencies.